Program in Macromolecular Structure, Motion, Control

The CORE laboratory provides facilities to all members of the Yale Center for Structural Biology for the investigation of macromolecular systems by X-ray crystallography and X-ray small-angle scattering, including both instruments for data collection, and computers for data reduction and analysis. Among the computers available are several molecular graphics systems, which are vital to the activities of all users. The staff of the CORE laboratory maintains and upgrades CSB instrumentation, and assists users with data collection and analysis. The CORE staff also maintains the CSB website, which is heavily used by structural biologist both inside and outside Yale. This invaluable resource provides its users with access to all the programs and data bases that are generally useful to structural biologists. The programs on the web site are upgraded as new releases appear, and documentation is provided for many of them to further assist users.